BRIDGES TO PHDS IN SPEECH PATHOLOGY AND AUDIOLOGY

DESCRIPTION (Adapted from Applicant's Abstract): The University of Iowa (UI) Department of Speech Pathology will develop and maintain a program to recruit and retain members of under represented minorities into its Ph.D. training program. The goal of this program is to fortify the pipeline between the UI an institutions that serve large numbers of minority students. This program will establish a direct link at the departmental level with Howard University (HU) and Our Lady of the Lake University (OLL). The faculty at HU and OLL working with UI faculty will select students who will participate in the program. UI faculty will serve on the students Masters Thesis committees and the students will work in their UI mentor=s laboratory during the summers. Each student wil have a plan of study which will be designed to optimize preparation for doctoral level study. In addition the program will coordinate Research Methods courses offered by the three institutions and sponsor a series of video-tele-conferences linking the UI with HU and OLL. Students and their mentors will also travel to national professional meetings together to further the students enculturation into the research community. Students who successfully complete their Master=s degree in this program will be admitted into the UI doctoral program and receive a Graduate Opportunity Fellowship. Ke to the long term success of this program is the development of direct faculty-to-faculty enduring contacts between UI faculty and their counterparts at HU and OLL.